Tetraacylated lipid A enhancement of checkpoint blocking cancer immunotherapy

PROJECT SUMMARY
Immune checkpoint inhibitor (ICI) therapy is a therapeutic approach that blocks pathways that inhibit anti-tumor
immunity and activates the immune system to fight cancer. Although ICI therapy has seen significant success
in some patients, unfortunately, most eligible patients still fail to respond to treatment. Several studies have
highlighted the modulatory capacity of the microbial composition of the gut microbiome as well as certain
organisms to direct a patient’s response to ICI. Our preliminary data show that the human gut commensal
Bacteroides ovatus 8483 has the capacity to enhance ⍺-PD-L1 (Programmed Death-Ligand 1) therapy in
germ-free (GF) and antibiotic-treated mice. The lipooligosaccharide (LOS) of B. ovatus is a major cell surface
molecule comprising about 50% of the surface of this microbe’s outer membrane. The LOS exists naturally in
several different structural analogs. We have found that among the many analogs of lipid A produced by B.
ovatus, an orally delivered tetra-acylated monophosphorylated lipid A (4A-MPLA) can potently enhance the
efficacy of ⍺-PD-L1 in mice that would otherwise fail to clear tumors. We propose to determine whether 4A-
MPLA could serve as a novel therapeutic for enhancing the current cancer immunotherapy arsenal. Our long-
term goal is to use 4A-MPLA in combination with PD-1 pathway blockade to treat cancer patients, particularly
non-responders to ⍺-PD-L1 alone.
Over the course of the next two years, we aim to understand: 1) the cell types and signaling pathways by
which 4A-MPLA influences local and systemic improvement of the ⍺-PD-L1 response, and 2) understand the
types of cancers that may respond to this treatment. Given our preliminary studies demonstrating the effect of
B. ovatus on colonic regulatory T cells (Tregs), we hypothesize that B. ovatus is affecting peripheral Tregs in
the colon and disrupting their ability to restrain antitumor immunity. To test this hypothesis, we will compare the
immune profiles of cells in several tissues including the gut lamina propria, mesenteric lymph nodes, tumor
draining lymph nodes, and the tumor itself in gnotobiotic, antibiotic-treated, and specific-pathogen-free (SPF)
mice treated with 4A-MPLA compared to controls. Tregs as well as other relevant compartments of the tumor
microenvironment (TME), such as CD8+ and CD4+ T cells, NK cells, NKT cells, B cells, dendritic cells, M1 and
M2 macrophages, and monocytic and granulocytic myeloid-derived suppressor cells, will be analyzed in mouse
tumor models for immunologic responses to ⍺-PD-L1 therapy with or without 4A-MPLA. Finally, we will
determine which murine tumor models respond to this therapy to better predict its clinical applicability.

Public health relevance
Narrative We have discovered a molecule from the microbiome that enhances checkpoint blocking therapy in 2 experimental models of cancer. This molecule is a glycolipid that is found on anaerobic gram-negative bacteria that live in the intestine and is a tetraacylated monophosphorylated analog of lipid A (4A1P-MPLA). Using a synthetic form of 4A1P-MPLA that enhances regulatory T cells in the gut, we will determine mechanisms of action and breath of therapeutic targets.